Good Bowls: Empowering Communities to Achieve Good Food Access and Health Equity

Diversity Supplement Abstract
Low-income, ethnic minority status, and rural residence are strong predictors of chronic
diseases such as cardiovascular disease, type 2 diabetes, and obesity. Poor nutrition and food
insecurity contribute to an increased risk of chronic disease, a significant public health concern
among adults and children in low-income households. Equiti Foods developed Good Bowls as
healthy, affordable, good-tasting, locally-produced frozen meals to address both healthy food
access and economic opportunity. While Good Bowls fills a critical need, learning food resource
management skills can improve nutrition quality by helping families purchase healthy foods
while stretching dollars. Developing culinary skills also increases cooking confidence and
teaches individuals to select and prepare healthy meal options. Delivering culinary and food
resource management education through mobile health (mHealth) holds promise to easily help
low-income individuals acquire new skills and reinforce nutrition behaviors. Thus, this diversity
supplement aims to pilot test tailored educational messages, videos, and text-message
reinforcement to encourage the uptake of culinary and food resource management skills
(CulinaryFRM going forward). We hypothesize that those receiving CulinaryFRM education will
have higher diet quality (assessed using the modified Med-Diet 14 item validated screener in
the parent study). The Specific Aims of this diversity supplement are: (1) to pilot test
CulinaryFRM, randomizing the participants in the delayed intervention control arm of the parent
study to either Good Bowls + Worksite-App nudges and home-based virtual coaching + Home-
based CulinaryFRM or Good Bowls + Worksite-App nudges, (2) assess the feasibility and
acceptability of delivering CulinaryFRM via the mobile phone-based app of the parent study, (3)
determine the efficacy of CulinaryFRM on diet quality (primary outcome assessed using the
Med-Diet 14 item validated screener), culinary skills, and food resource management (FRM)
skills. The information gained from this research will provide the necessary foundation for the
development of mHealth-based personalized culinary nutrition-focused interventions to improve
health outcomes among low-income families.

Public health relevance
Narrative Developing culinary skills increases cooking confidence and teaches individuals to select and prepare healthy meal options. Delivering culinary and food resource management education through mobile health (mHealth) holds promise to easily help low-income individuals acquire new skills and reinforce nutrition behaviors. Thus, this diversity supplement aims to pilot test tailored educational messages, videos, and text-message reinforcement to encourage the uptake of culinary and food resource management skills.